The Role of Ceramides in the Pancreatic Beta Cell

SUMMARY
This proposal explores the hypothesis that sphingolipids such as ceramides serve as common, cell-autonomous
signals that impair beta cell function and contribute to the development of type 1 and type 2 diabetes. The idea
is predicated upon data presented herein showing that the administration of a pharmacological inhibitor of
ceramide biosynthesis to rodents preserves the beta cell and prevents the development of both forms of the
disease (i.e. in Zucker Diabetic Fatty rats as well as Non-Obese Diabetic mice). The theory is further supported
by studies in human and mouse islets implicating ceramides as intermediates linking saturated fatty acids and
inflammatory cytokines to the impairment of insulin secretion, mitochondrial function, and beta cell survival. We
will evaluate this hypothesized role for ceramides and its metabolites in the pancreatic islet through the following
aims:
· First, we will study new mouse models allowing for the conditional, beta cell-specific modulation of genes
involved in ceramide synthesis or degradation, allowing us to determine whether the lipids are either (a)
necessary or (b) sufficient for beta cell failure and the onset of frank hyperglycemia.
· Second, we will test the efficacy of a new class of ceramide synthesis inhibitors targeting dihydroceramide
desaturase-1 as therapeutics that improve insulin secretion and prevent type 1 or type 2 diabetes in
rodents.
· Third, we will determine the mechanisms through which ceramides impair the function of mouse and
human islets. We will test a hypothesized role for ceramides as drivers of metabolic reprogramming using
state-of-the-art metabolic tracing, mitochondrial phenotyping, and cell function assays.
Findings obtained from these studies could uncover new nutrient-sensing and/or inflammatory mechanisms that
modulate islet function, survival and growth. Moreover, the translational component of this work could lead to
the development of new therapeutic alternatives for preventing or treating diabetes.

Public health relevance
NARRATIVE Following consumption of a meal, pancreatic beta-cells secrete insulin, a hormone that promotes the uptake and storage of carbohydrates and other nutrients in skeletal muscle while simultaneously repressing glucose efflux from the liver. Diabetes mellitus results from insulin availability that is insufficient to meet tissue needs, and both the type 1 and type 2 forms of the disease are associated with decreased beta-cell mass and insulin production. Herein we propose to test the hypothesis that a family of nutritional byproducts termed ceramides contribute to this decline in beta cell function that drives both forms of the disease.